Understanding the Development of Social Disconnection in Youth

Project Summary
Social disconnection and loneliness surge in adolescence and have a negative impact on youth physical and
mental health. Furthermore, social disconnection during this life stage predicts difficulties forming and
maintaining relationships in adulthood, with similarly negative consequences for adult physical and mental
health. A key underlying process for adolescents’ risk of social disconnection may be their heightened biological
stress reactivity. A major theory by Taylor postulated that the stress response can activate two primary social-
behavioral profiles, “fight-or-flight” (i.e., an increase in conflict or social withdrawal), or “tend-and-befriend” (i.e.,
an increase in prosocial and affiliative behavior). However, most prior research on Taylor’s model has been with
adults, creating a gap in our understanding of when and why these profiles emerge in development, and how
biology, personality, and social relationships contribute to youths’ tendencies to respond to social challenges
with socially distancing versus socially engaging behaviors. The current project aims to fill these critical gaps by
revealing the biological, personality, and relationship characteristics that differentiate these two social-behavioral
stress profiles. To meet this objective, the research team will undertake two specific aims. First, the team will
recruit a new sample of 280 adolescents ages 11-16 years old to complete a social evaluation stressor and
biobehavioral assessments in the laboratory, followed by psychosocial assessments one year later. The team
will test the role of social relationships, personality, and biological characteristics (oxytocin, adrenocortical,
autonomic, and inflammatory activity) in differentiating “fight-or-flight” versus “tend-and-befriend” profiles in
response to the social evaluation stressor, and predict longitudinal change in loneliness using these profiles. For
the second aim, the team will conduct new analyses of existing data from a longitudinal study of 674
predominantly low-income Mexican-origin Hispanic youth in California, who have been followed from age 10 to
age 24. New assays of stored, frozen samples for oxytocin will also be conducted in a subsample of 229 youth
from this study who at age 17 completed a social exclusion protocol with biological assessments (adrenocortical,
autonomic, and inflammatory activity). The second aim is to identify the prospective contributions of social
relationships and personality to adolescents’ “fight-or-flight” versus “tend-and-befriend” profiles in response to a
social exclusion stressor, and use these two profiles to predict change in time spent alone longitudinally. With
the full sample of 674 Mexican-origin youth, we will test that relationship quality and youth personality will predict
increased versus decreased time spent alone during waves when school transitions occur. By accomplishing
these aims, this project will deliver a multi-faceted understanding of how social disconnection develops and
identify key biobehavioral targets that can be modified to improve social connectedness in adolescence and
beyond.

Public health relevance
Project Narrative The proposed research is relevant to public health because social disconnection is a major risk factor for poor physical and mental health and it rises steeply during adolescence. The project is relevant to NICHD’s priorities because it seeks to understand social isolation across development, reveal family-level risk and protective factors for social disconnection, and identify targets for behavioral and biological intervention.